Core A - Administrative Core

PROJECT SUMMARY/ABSTRACT
CORE A: ADMINISTRATIVE CORE
The Administrative Core provides administrative leadership, organizational structure, management,
communication, and networking for all HIV researchers between Lifespan/Brown University and Boston
University/Boston Medical Center; our Departments of Health, community-based organizations, and international
sites. Core A will accomplish this through the following aims: 1) Provide leadership, administrative structure, and
fiscal management to support collaborative and innovative clinical, behavioral, translational, and basic science
research directed at HIV prevention, treatment, cure and co-morbidities; 2) Support the Cores to fulfill their
missions and deliver services to increase the footprint and visibility with stakeholders and partners by
coordinating oversight of six Cores; one Scientific Working Group (HIV and Oral Health); CFAR-Community
Engaged Research Council (C-CERC), and the Diversity, Equity, Inclusion and Belonging (DEIB) program,
including evaluation, guidance and setting priorities and services that are consistent with the NIH HIV priorities
and Ending the HIV Epidemic; 3) Facilitate collaboration and communication across our CFAR, partner
institutions, other CFARs, and communities, engage the C-CERC for input regarding Core services and scientific
activities, work with members of our Internal Advisory Committee and External Scientific Advisory Committee
and to review the progress of our CFAR services and implement changes as necessary; and 4) In collaboration
with the Developmental Core, provide leadership in training, education, and mentorship of early stage and early
career investigators by providing direct funding for innovative and collaborative research efforts, promote
recruitment of new investigators and the training of early stage investigators, particularly under-represented
minority investigators, in high priority HIV/AIDS research. Efforts in this aim will focus on assuring a training
pipeline for future scientists with an interest towards innovative HIV research.
The Administrative Core successfully increased our institutional support through a negotiated indirect cap of
25%, no indirect costs for developmental awards, and monetary support from both institutions specifically
designated for developmental awards for early stage investigators both domestically and globally. In this cycle,
our institutions have hired 34 new faculty in HIV research.